NORMAL AND ABERRANT MECHANISMS OF INFLAMMATION, REPAIR AND REGENERATION

The objective of this research program is to define the molecular mechanisms that regulate the inflammatory process. One of the key mediators of the inflammatory process is TGF-beta1 and our recent studies have focused on TGF-beta-1 homozygous null mice in which the gene for TGF- beta-1 has been inactivated as a model of autoimmune-like pathology similar to Sjogren's Syndrome. Moreover, beyond its immunoregulatory role, TGF-beta-1 is considered essential to healing and tissue repair because of its growth and synthetic influences on mesenchymal cells. In this regard, we have taken advantage of TGF-beta-1-gene targeted mutant mice which over-express TGF-beta-1 (TGF-beta-1 transgenics) or in which TGF-beta-1 has been inactivated (TGF-beta-1-/-; null mutation) or partially inactivated (TGF-beta-1+/-; null mutation heterozygotes), to explore the role of this peptide in a model of fibropathology. Schistosomiasis mansoni, an extracellular parasite, which is a major cause of hepatic fibrosis in many developing countries, triggers a granulomatous inflammatory reaction in response to its eggs that lodge in the liver. The persistent granulomatous response leads to prolonged matrix synthesis and hepatic fibrosis during which TGF-beta-1 is produced. Matrix production and fibrosis in response to natural infection with S.mansoni worms exhibited distinct profiles in TGF-beta-1 gene targeted mice, consonant with their levels of TGF-beta-1. Although fibrotic manifestations appear dependent on TGF-beta-1 levels, fibrosis is not eliminated in the absence of TGF-beta-1, nor overwhelming in mice overexpressing this fibrogenic peptide. These observations emphasize the multifactorial nature of the signals involved in the complex pathophysiology of this and other fibrotic diseases. Nonetheless, as a link in the cytokine cascade, TGF-beta-1 represents a potential target for novel therapies in fibrotic disorders. Another effector molecule in inflammation and repair is nitric oxide (NO), the synthesis of which is regulated by TGF-beta.